POTENTIATION OF AGONIST-INDUCED PLATELET ACTIVATION BY PURIFIED HEMOGLOBINS

Purified and modified hemoglobins are potential blood substitutes, however, significant toxicities are associated with their in vivo application. We have studied the effects of purified hemoglobin A0 (HbA0) (10-9 - 10-6 M) on platelet reactivity. HbA0 did not activate platelets when added alone but potentiated agonist-induced platelet aggregation in a concentration dependent manner. HbA0 (10-6 M) nearly doubled the extent of platelet aggregation induced with submaximal concentrations of collagen, thrombin and arachidonic acid but did not potentiate aggregation induced with ADP or ADP/epinephrine. The potentiation was not blocked by indomethacin, apyrase, yohimbine, superoxide dismutase or catalase. Heme-mediated reactions only partially accounted for this potentiation since methemoglobin A0, carbon monoxide- treated HbA0 and cyanomethemoglobin A0 potentiated aggregation 62-97% as well as native hemoglobin A0. Affinity chromatography of solubilized platelet membranes on hemoglobin-agarose revealed an interaction of hemoglobin with a 125 kDa and a 95 kDa protein. These proteins were identified as the aIIbBeta3 integrin complex (glycoprotein IIb/IIIa) by immunoblotting with monoclonal antibodies. This interaction was prevented with free HbA0 in solution suggesting a specific interaction. Hemoglobin may potentiate platelet aggregation by modulating the interaction of integrin aIIbBeta3 and fibrinogen.The significance of this project lies in identifying interactions between circulating blood cells and hemoglobin-based blood substitutes in vitro and thus predict potential toxic reactions when the blood substitutes are used in vivo.